Oxygen-eluting scaffolds for cranial bone regeneration

Each year, there are approximately 200,000 craniofacial fractures requiring bone transplantation in the US with
an economic burden of $2B. These injuries often require multiple complex surgeries, which do not achieve
adequate functional or aesthetic restoration. To address this limitation, the field of tissue engineering has
employed advanced approaches that combine a patient’s own cells with customized bioactive scaffolds to
induce regeneration. For efficacious clinical translation of tissue engineering strategies, it is crucial to develop
them as point-of-care technologies in which the harvesting of cells, their packaging into scaffolds, and
immediate transplantation into the defect site will take place within a single surgical procedure. A major hurdle
of this strategy is that the hypoxic wound microenvironment impedes the ability of surviving cells to orchestrate
regeneration. To overcome this limitation, we propose to design scaffolds capable of delivering oxygen (O2)
along with the cells. Specifically, we will embed O2-eluting microtanks (µtanks) – hollow, polymeric
microspheres capable of ‘storing’ O2 at elevated pressures and slowly releasing it into the cellular
microenvironment – into scaffolds comprised of polycaprolactone (PCL) and decellularized bone matrix (DCB)
that are 3D-printed in precise, anatomic shapes. To effectively design O2-eluting, PCL-DCB-µtank scaffolds
and track the enhanced viability and therapeutic efficacy of transplanted stromal vascular fraction (SVF) cells
harvested from lipoaspirate, we will utilize multimodal in vivo optical imaging. This will provide quantitative data
on the in vivo microenvironmental factors that impact stem cell survival and tissue regeneration following
transplantation and uniquely inform the design process leading to more effective, next-generation biomaterial
scaffolds. We hypothesize that the delivery of oxygen using our microtank technology for up to four days will
enhance stem cell survival, vascularization and bone formation within the defect and that by non-invasively
monitoring the effects of oxygen delivery via a cranial window, we can optimize the design of the scaffold. In
Specific Aim 1, we will manufacture 10-50 µm diameter biodegradable polyvinyl alcohol microtanks,
incorporate them into the struts of the 3D-printed scaffolds, and validate the spatiotemporal O2 gradients within
the scaffolds in response to varying the microtank concentrations and loading pressures. In Specific Aim 2, we
will integrate experimental data of O2 concentrations most favorable to vascular morphogenesis/osteogenic
differentiation of SVF with numerical simulations to predict the scaffold designs that provide favorable
spatiotemporal O2 gradients to promote tissue regeneration. In Specific Aim 3, we will utilize non-invasive,
multimodal imaging to dynamically monitor transplanted cells and vascular assembly in PCL-DCB-µtank
scaffolds and use this to enhance scaffold design. We will test the optimal designs in a scaled-up, stringent,
vasculature-limited model of bone regeneration. The complementary tissue engineering/imaging strengths will
provide unprecedented insight into bone regeneration and produce novel platform biomaterial technologies.

Public health relevance
This study proposes the design, development, and testing of 3D-printed polycaprolactone-decellularized bone matrix-microtank scaffolds. The scaffolds will provide controlled release of oxygen to enhance the survival and regenerative capacity of stromal vascular fraction cells transplanted into critical sized bone defects. We will use multimodal imaging through a cranial window to provide quantitative feedback on microenvironmental factors and effectively maximize stem cell survival, vascularization and bone formation in larger defect models.